Proteomics and Metabolomics

PPG Proteomics and Metabolomics Core B Summary
The Proteomics and Metabolomics Core (Core B) provides state-of-the-art instrumentation, methodology,
and expertise in analytical proteomics and metabolomics to all investigators in this PPG. A unique feature of the
Proteomics and Metabolomics Core is the availability of cutting-edge quantitative proteomics analysis
technologies that allows high sensitivity measurements of proteome changes in rodent and ex vivo models of
gastric cancer. New services in this renewal application include discovery and targeted metabolomics as
well as tissue imaging mass spectrometry (IMS). Core B provides 1) identification and quantitation of proteins in
complex samples, 2) analyses of protein modifications, 3) quantitative analyses of lipid and metabolite
abundances, 4) quantitative analysis of iron, and 5) molecular imaging of gastric tissue using IMS.
Core staff provide consultation on experimental design as well as hands on sample preparation, mass
spectrometry analysis, and primary data analysis. Multiple high performance mass spectrometers for LC-MS/MS
experiments are available for the proposed analyses. In addition, advanced methods are available including:
multidimensional LC-MS/MS for protein identification from complex samples, data-independent acquisition (DIA)
for greater proteome coverage, and high spatial and mass resolution imaging methods for tissue analysis with
tissue annotation coordinated with Gastric Histopathology Core A. Conversely, Core A will synergize with
Core B by using immunohistochemistry to localize protein targets identified by proteomics analysis. Core B also
provides relative quantitation using stable isotope differential labeling strategies, such as TMT, for samples
derived from animal models, including organoids. Validation of protein expression or metabolite abundance
changes is accomplished using targeted multiple reaction monitoring LC-MS/MS methods.
Project 1 (Peek) will utilize metabolomics methods to measure metabolite changes in H. pylori strains 1) treated
in vitro with deoxycholic acid (DCA) or 2) isolated from mice treated with DCA, as well as IMS methods to localize
bile acids in H. pylori-infected gastric tissues. Project 2 (Wilson) will utilize proteomic analyses to measure
changes in patient-derived gastric organoids infected with H. pylori and treated with SMOX inhibitors and
electrophile scavengers. Metabolomics will also be used to measure metabolite changes in infected and treated
mouse gastric tissue. Project 3 (Cover) will employ metabolomics methods to examine metabolite changes in
a gerbil model in response to dietary factors that predispose to gastric cancer. Project 3 will also utilize IMS
methods to measure changes in metabolites, proteins, and lipids in gastric tissue in a spatially-resolved manner
in animal models and in human tissue microarrays. In addition, Project 3 will use elemental analysis methods to
measure iron uptake in H. pylori as a function of environmental salt concentrations.

Public health relevance
PROTEOMICS AND METABOLOMICS CORE B NARRATIVE The use of state-of-the-art proteomics, metabolomics, and imaging mass spectrometry technologies in the three Projects will identify protein, lipid, and metabolite changes in gastric cells and bacterial cells that play important roles in gastric cancer.